Brain Tissue Resource Center for Alcohol Research

Project Summary
The effects of chronic and heavy alcohol use on individuals and communities are of major public
health and socio-economic concern. Research aimed at reducing alcohol intake and organ damage,
must be underpinned by a sound knowledge of the pathobiology of alcohol use at a cellular and
molecular level. A key resource for such research is access to high quality, extensively characterized
tissue from individuals with a history chronic alcohol use and matched controls. The NSW Brain
Tissue Resource Center (BTRC) is a brain bank that was established to facilitate research into alcohol
use and specifically alcohol-related brain damage (ARBD). The BTRC, based at The University of
Sydney, provides human post-mortem brain tissue, demographic data and clinical information, to
researchers worldwide. Tissues are collected from individuals with alcohol use disorders and controls
through a prospective donor program or retrospectively following forensic autopsy. Case selection is
based on a range of specific inclusion and exclusion criteria to maintain cohorts that are easily
matched and relatively uncomplicated by co-morbidities. Tissues are prepared so that fresh frozen,
formalin-fixed and formalin-fixed, paraffin-embedded samples are available to researchers.
Preparation and storage of tissues has been developed, and continually modified, to produce high
quality specimens for implementation across the widest range of research techniques. All cases
undergo a thorough neuropathologic examination by a specialist pathologist and are assigned DSMIV
and DSM 5 diagnoses following review of medical records and medical, family history and lifestyle
information provided by the donor and/or their family. Cohorts of people with a history of alcohol use
and controls with and without complicating factors (e.g. comorbid cigarette smoking, liver disease) are
then established to allow researchers to address specific questions. Access to tissue is open to any
researcher with institutional ethics approval, following approval by an NIAAA-convened Scientific
Advisory Board to ensure appropriate and efficient use of the resource. The BTRC holds institutional
ethics approval to collect, hold and distribute tissues and associated data. Its operations are overseen
by a Director, Associate Professor Greg Sutherland, and Manager, Ms Julia Stevens, both of whom
have extensive experience in biobanking and alcohol research and have, over their careers,
contributed directly to 22 alcohol-related research articles. Since 2000, the BTRC has facilitated 277
publications on various aspects of alcohol use, with another 400+ publications on various neurological
and psychiatric disorders.

Public health relevance
Project Narrative The NSW Brain Tissue Resource Center provides well-characterized, high quality central nervous system tissues, associated clinical and lifestyle information and other data to researchers worldwide. Human post-mortem brain tissue is a proven and essential resource for studying the cellular and molecular basis of addiction and alcohol-related brain damage. In addition, human tissue and data- based studies augment clinical and preclinical studies to identify novel therapeutic targets for persons living with alcohol use disorder.